NORTHWESTERN-UNIJOS MENTORED PROGRAM FOR ENHANCED RESEARCH ADMINISTRATION (NUMPERA)

PROJECT SUMMARY
The University of Jos has a total of 1,612 academic staff with over 350 engaged in intensive or sponsored
researches. In the history of international grant-supported researches in the university, the National Institutes
of Health (NIH) have sponsored more projects, yet mostly sub-contracts. Jos has a history of NIH funding,
both as prime and as a subaward with the majority of awards being subawards, from Fogarty, NCI, and
recently received its funding from National Institutes Allergies of Infectious Diseases (NIAID), the Sequelae
of Lasser Fever awarded in 2018 and the West African Centre for Emerging Infectious Diseases (WACEID)
awarded in 2020. The University has 15 faculties (colleges/schools): Seven of these are clinical and
biomedical sciences and the most active in securing grants locally and internationally. The clinical/biomedical
science faculties require vigorous research administrative support to perform maximally. The 8 Faculties
spreads through humanities, education, law, physical and earth sciences, engineering, computer sciences,
agriculture and social sciences and require support too. The pre- and post-award activities for all faculties at
University of Jos are supported by the Office for Research Development (ORD) which is responsible for all
grants management activities except for financial management. Financial management is led by one person
who supports both University of Jos and Jos University Teaching Hospital. To support these faculties, the
lead administrators from ORD and for financial management will be trained in the NIAID/NIH grant funding
and management practices and practical experience at Northwestern University Chicago. These trainings
will be stepped-down to the ORD staff, mentoring programs developed for junior RAs and fora to enhance
faculty members understanding of NIAID/NIH guidelines. The program will deploy enhanced business
approaches for ORD to support faculty members in developing successful research grant applications as well
as administrative efficiency in managing researches. The NIAID funding will also help reposition the units of
the ORD, establish some departmental research offices and train them, develop policies for research
operations, institute sustainability of research administration and management. The investment in work tools
will enhance the performance of the research office, provide electronic solutions for efficient research
enterprise and extend training on the NIAID/NIH grants management policies and funding opportunities to
some local research institutions in Nigeria. The expected outcome of this program is an improved system of
research administration in UNIJOS, increased NIAID/NIH funding, adherence to grants management policies
and positioning the ORD to effectively galvanize and coordinate the institution to a research intensive

Public health relevance
PROJECT NARRATIVE The University of Jos is sited in the North-Central Nigeria; it has the capacity to provide solutions to the disease burden bedeviling a population of over 29,252,402 million Nigerians if research administration and research capacity training is enhanced. The Institution has played vital roles in curbing some infectious diseases in North-Central Nigeria through the U.S. President’s Emergency Plan for AIDS Relief (PEPFAR) and Centre for Disease Control (CDC) till date and with the NIAID-WACEID and Sequelae of Lasser Fever, can achieve more if investments continue from the NIH. The goal of this project is to strengthen grants management capacity at the university through advanced training of senior grants administrators and the implementation of sustainability initiatives which will ultimately support the development of more capacities in the biomedical sciences, improved funding and partnerships across Africa and the United States, manpower development, efficient research management systems, enabling environment for health research outputs to reduce the disease and poverty burden bedeviling the Africa population for sustainable development.